Innovations in the Science of Public Reporting of Provider Performance

DESCRIPTION (provided by applicant): The public reporting of comparative provider performance is widespread among public and private purchasers of health care. A key goal of these reporting efforts is to provide consumers with comparative information that can help them choose high-value providers (i.e., high-quality, low-cost). However, the evidence to date shows challenges in consumer use of these reports, reflecting problems in their design, including the underlying analytic methods, the content and display of information, and dissemination to consumers at the point when health care decisions occur. While there is great interest in and need to communicate the differential value of providers to consumers given efforts to increase consumer cost sharing and selection of high value services and providers, there has been little progress in developing a value metric that combines cost and quality information. Challenges exist in combining measures to create a measure of value where cost and quality measures have weak associations. Current attempts at showing value have focused on side-by-side displays of cost and quality measures. Moreover, as measurement pushes further into areas where the number of events per provider is low, problems arise in obtaining a strong signal on a provider's true performance. We propose to develop an innovative framework that conceptualizes health care value as a two-dimensional construct. Our approach will estimate optimal provider performance across the cost-quality continuum, allowing for fuller consideration of cost-quality tradeoffs in public reports. Aim 1 of the project is to improve the precision and substantive relevance of the information provided to consumers in public reports of health care provider quality. We will do this by (a) assessing the risk of misclassifying physicians into performance tiers and associate reliabilities of physician profiles with misclassification risk and (b) examining whether performance summaries that are tailored to specific reporting goals (e.g., ranking, establishing percentiles or tiers of performance) result in more accurate and precise public reports of small providers' performance as compared to the standard approach of using provider-specific means. Aim 2 is to develop a rigorous cost-quality modeling framework to inform the public reporting of health care provider value. We will employ bivariate hierarchical modeling to obtain measures of the cost-quality tradeoff at each level of the provider hierarchy.

Public health relevance
Public Health Relevance of the Project: Our findings will help the sponsors of public reports minimize the frequency and severity of provider performance misclassification. The ultimate benefit from our project will be to strengthen the credibility of public reports, leading to increaed use by consumers, ultimately improving the value of health care delivered in the U.S. PUBLIC HEALTH RELEVANCE: This project aims to improve the precision and substantive relevance of the information provided to consumers in public reports of health care provider quality and cost. Public Health Relevance of the Project: Our findings will help the sponsors of public reports minimize the frequency and severity of provider performance misclassification. The ultimate benefit from our project will be to strengthen the credibility of public reports, leadng to increased use by consumers, ultimately improving the value of health care delivered in the U.S. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The public reporting of comparative provider performance is widespread among public and private purchasers of health care. The Agency for Healthcare Research and Quality (AHRQ)'s Health Care Reporting Compendium lists over 200 samples of 'report cards' of provider performance1. A goal of these reporting efforts is to provide consumers with comparative information that can help them choose high-value providers (i.e., high-quality, low-cost). However, the evidence to date shows challenges in consumer use of these reports2, 3, reflecting design problems including the underlying analytic methods, the content, and display of information, and challenges in disseminating the information to consumers. The performance measurement landscape has evolved and is growing more complex as the producers of public report cards work to expand the number and types of measures for which they are holding providers accountable4-6. As purchasers and payers develop performance dashboards with a multitude of measures, this creates challenges for how to best summarize information on provider performance in a way that provides accurate information for consumer decision making and which is easily interpretable. While there is great interest in and need to communicate the differential "value" of providers to consumers, given efforts to increase consumer cost sharing so that consumers will select high value services and providers (e.g., through reference pricing of drugs, procedures), there has been little progress in developing a value metric that combines cost and quality information. Challenges also exist when cost and quality measures have weak associations7. Current attempts to show "value" focus on side-by-side displays of cost and quality measures. As measurement pushes further into areas where the numbers of events are small per provider, problems arise in obtaining a strong signal on a provider's true performance. A tension exists between presenting simple and clear provider performance reports with meeting the needs of a variety of consumers of the information. Recommendations to improve the interpretability of public reports include presenting information in intuitive, graphical summaries, such as rank-ordering providers by mean performance8, 9. However, such well-intentioned steps risk misleading consumers, since ranks and means are often not equivalent and ranks are much more variable than means10. Public report sponsors often create tiered performance categories, in which statistical testing distinguishes above average, average, and below average providers. While this provides a useful accounting of uncertainty from the sponsor perspective, it may mask the fact to consumers that providers are not directly comparable across tiers. Further, there are concerns about the reliabilities of publicly reported quality and cost measures11-14. Reliability is a key metric to assess the suitability of a performance measure for profiling: it describes how well one can distinguish the performance of one provider from another. The risk of misclassifying provider performance is likely to be unduly high for low- reliability performance measures and providers who have a small number of events on which they are scored. Public reports that lack precision and substantive relevance to patient decision-making could derail quality improvement efforts. Effective public health care reports must address these challenges. We propose to develop an innovative model of health care value by characterizing optimal performance across the cost-quality continuum, allowing for fuller consideration of value in public reports13-15. We propose critical work to improve the precision and substantive relevance of the cost and quality inputs to the value metric. By examining the robustness of public reports to multiple reporting goals, we confront the reality that consumers are likely to over-interpret simple, easy-to-understand summaries of provider performance, such as assuming the performance of a top tier provider might significantly differ from that of a middle tier performer or selecting a provider based on rank-ordering mean performance. Our findings will help the sponsors of public reports minimize the severity of provider performance misclassification. The benefit from our innovations will be to strengthen the credibility of public reporting of health care provider performance, increase the demand for reports among patients, and lead to the delivery of high-value health care. Aim 1: Improve the precision and substantive relevance of the information provided to consumers in public reports of health care provider quality. (a) Assess the risk of misclassifying physicians into performance tiers. Associate reliabilities of physician profiles with misclassification risk. (b) Examine the extent to which performance reports that are tailored to specific displays (e.g., ranking, establishing percentiles or tiers of performance) result in more accurate and precise public reports of small providers' performance. Aim 2: Develop a rigorous cost-quality modeling framework to inform the public reporting of health care provider value. We will employ bivariate hierarchical modeling to obtain a measure of the cost-quality tradeoff. We hypothesize (i) jointly modeling cost and quality will result in more reliable public reports of both provider cost and quality than modeling each separately and (ii) the cost-quality relationship will be stronger at lower (e.g., physicians) versus higher levels of the provider hierarchy.